BI tims TOF fleX with MALDI-2 mass spectrometer

Summary
The Cellular Mass Spectrometry Facility has created unique protocols for the characterization of individual cells
and cellular organelles, for high spatial resolution mass spectrometry imaging of tissues and for correlated
molecular imaging. These measurement approaches are used by a broad range of NIH-supported researchers,
locally at the University of Illinois Urbana-Champaign (UIUC), regionally at collaborating institutions in Illinois,
Indiana and Wisconsin, and nationally. The overarching need is to replace two separate decade-old instruments
with a new matrix assisted laser-desorption ionization (MALDI) mass spectrometer that has greatly enhanced
performance specifications in terms of detection limits, mass resolution, ion mobility separations, analyses
speeds, and spatial resolution, among other advancements. More specifically, the requested Bruker timsTOF
fleX MALDI-2 system incorporates multiple design improvements, including MALDI-2 post-ionization, trapped
ion mobility, parallel accumulation serial fragmentation, dual sources, and many other design improvements
compared to alternative instruments. These advanced features and the associated figures of merit are enabling
for a range of NIH-supported users requiring single cell and tissue imaging measurements. The major molecular
targets include lipids, metabolites, peptides (including endogenous D-amino acid-containing peptides) and
proteins. Because the instrument is considered a strategic acquisition by UIUC, the administration is supplying
institutional funds to support the service contracts in years 2–5. This instrument will directly benefit three NIH-
supported centers and more than a dozen additional NIH-supported major users; the research of a broad portfolio
of research projects will be catalyzed with the acquisition of the Bruker timsTOF flex MALDI-2 instrument.

Public health relevance
Narrative The acquisition of a Bruker timsTOF fleX MALDI-2 mass spectrometer will enable a broad array of volume-limited molecular analyses related to the mass spectrometry imaging of tissues and characterization of individual cells and cellular organelles. Its advanced features allow faster acquisitions from a greater range of smaller sample sizes, providing vastly improved chemical information that will significantly benefit biochemical investigations impacting human health, including disease progression, diagnosis and treatment. The system will be located in the Cellular Mass Spectrometry Facility at the University of Illinois Urbana-Champaign, known for its ability to probe lipids, metabolites and peptide complements from individual cells and tissues, and will support a wide range of NIH-funded user projects.